A novel social media approach to #identification and #screening for hazardous drinking among diverse non-college young adults

PROJECT SUMMARY
Young adults have higher rates of alcohol use and experience more alcohol-related harms than other age
groups, but are less likely to seek treatment. Further, young adults not attending college, who are more likely to
be from non-White racial/ethnic groups, may be particularly underserved with respect to alcohol screening and
intervention efforts. As such, it is critical that we expand alcohol screening strategies to reach non-college
young adults, a traditionally underrepresented group. Social Networking Sites (SNS; e.g., Twitter, Instagram)
are exciting platforms through which to identify at-risk young adults from diverse backgrounds, many of whom
use SNS. Consistent with Self-Presentation Theory, it is common for young adults to publicly post about
serious alcohol-related consequences (e.g., alcohol-related blackouts), which may reflect their actual drinking
behavior and therefore signal the need for intervention. Despite their potential to be used for screening, SNS
have rarely been leveraged for this purpose. Thus, our broad goals are to determine maximally sensitive and
specific keywords within non-college young adults’ SNS posts that can be used in automated surveillance
and/or screening efforts, and to determine how to maximize acceptability of SNS-based screening for diverse
samples of heavy drinking non-college young adults. In Aim 1, we will determine content of public SNS posts
that serves as a marker of hazardous drinking across a diverse group of non-college young adults by
conducting online surveys with n=800 young adults who endorse posting about alcohol on SNS. Participants
will report on their alcohol use, alcohol-related consequences, and whether they meet criteria for hazardous
drinking (via the Alcohol Use Disorder Identification Test; AUDIT). They will also provide permission to collect
their public SNS posts from the prior month. We will identify alcohol-related keywords/phrases in SNS posts
that have the highest sensitivity and specificity in identifying hazardous drinking (i.e., AUDIT score >8). We will
also explore whether certain terms are used more often, or are more sensitive/specific indicators of hazardous
drinking, among respondents from different sex/gender and racial/ethnic groups. In Aim 2, we will conduct 80-
96 individual interviews with non-college young adults (stratified by racial/ethnic group and sex/gender) to
obtain feedback from potential target individuals on how to maximize acceptability of and engagement with
SNS-based contact for screening and intervention. By addressing these aims, the proposed R21 will provide a
blueprint for future use of SNS to identify and potentially provide brief intervention for hazardous drinkers in an
automated fashion. Such methods have great potential to improve public health by reducing alcohol misuse
and negative consequences among non-college young adults across the US, with particular value for those
from traditionally underrepresented racial and ethnic groups.

Public health relevance
PROJECT NARRATIVE Non-college young adults from diverse racial/ethnic backgrounds engaging in heavy drinking are at risk for severe negative consequences (e.g., sexual assault, injuries; blackouts) but are hard to reach for screening and intervention. Popular social networking sites (e.g., Twitter, Instagram) are potential platforms to identify and screen individuals in need of, but who do not independently seek out treatment. This research has the potential to have a major impact on public health by developing methods to extend the reach and impact of screening for at-risk non-college young adults from diverse backgrounds.